Innate Immune Mechanisms Contributing to Cancer Growth in Obesity

Supplement Project Summary
Obesity (body mass index ≥30 kg/m2), which affects at least one-third of the U.S. population, is more prevalent
among African American and Hispanic populations and increases the risks of both developing and dying from
certain cancers. However, the cellular and molecular mechanisms underlying these risks are unknown. Our
studies demonstrate that colorectal cancer (CRC) and other tumors grow considerably faster in diet-induced
obese mice due to the immunosuppressive actions of the acid-sensing receptor, G-protein coupled 65 (GPR65),
on tumor-associated macrophages (TAMs). In the parent project, we are analyzing the intracellular signals from
GPR65 that alter TAM function and tumor growth in obese mice, identifying the mechanism by which a high-fat
diet (HFD) promotes GPR65 signaling in TAMs, and assessing the effects of targeting GPR65 for tumor
immunotherapy in obese and non-obese mice. Data from the parent project indicate that altered lipid metabolism
is responsible for upregulating GPR65 expression on TAMs in the tumors of obese mice. Since the lipid profile
in tumors of obese humans is nearly identical to that of tumors from obese mice, we believe there is a high
likelihood that tumors from obese humans will display a similar immune profile. In the proposed supplement
project, we will extend our studies to human cancers including CRC, hepatocellular carcinoma (HCC), pancreatic
adenocarcinoma (PDAC) and breast carcinomas in order to test the hypothesis that GPR65 expression on TAMs
is associated with obesity, altered TAM function and alterations of other immune cells in the tumor
microenvironment. We further hypothesize that these effects of obesity on immune cells in cancer are equivalent
in African American, Hispanic, Asian and non-Hispanic White populations and not determined on the basis of
race or ethnicity. To analyze the tumors, we will use mass cytometry (CyTOF) to examine the frequencies,
surface, and cytokine profiles of immune cells in the tumor, use single cell RNA sequencing (scRNA seq) to
analyze the functional profiles of these cells and use CODEX to analyze the spatial relationships between TAMs
and other immune cells. We will then compare the results between tumors from patients of different racial and
ethnic backgrounds. The results of these experiments are expected to confirm both of our hypotheses and
provide a strong rationale for future studies in which these hypotheses are tested in larger populations, and novel
therapies targeting GPR65 are developed and evaluated in clinical trials.

Public health relevance
Project Narrative Obesity, which is more common among African American and Hispanic populations, increases the risk of developing and dying from certain cancers such as breast and colon cancer. We discovered in obese mice with cancer that this increased risk is caused by a molecule on immune cells called GPR65 and that eliminating GPR65 results in markedly reduced cancer growth. In this project, we will determine if GPR65 is present in the cancers of obese but not nonobese patients and whether its presence differs between African American, Hispanic, Asian and non-Hispanic White populations.